Interrogating MRCK Protein Kinases in Ovarian Cancer

The majority of recurrent ovarian cancers spread to the peritoneal cavity in the form of ascites, where tumor cells
grow as spheroids, and metastasize to other organs causing morbidity and death. The overall goal of this
proposal is to define the mechanisms by which protein kinases control spheroid growth and metastasis of ovarian
cancer cells, and use this information to develop kinase inhibitor therapies for the treatment of recurrent ovarian
cancer. The Cdc42 downstream effector protein kinases MRCKα and MRCKβ (MRCKs) are highly expressed
in ovarian cancer and have been implicated in cell migration, invasion and metastasis. Strikingly, we recently
discovered that inhibition of MRCK impaired actin cytoskeleton remodeling and focal adhesion assembly
blocking cell migration and spheroid growth and invasion of ovarian cancer cells, revealing MRCK as a new and
untapped target for the treatment of recurrent ovarian cancer. Moreover, our most recent findings showed
inhibition of MRCK blocked tumor growth and induced tumor apoptosis in ovarian cancer xenografts and ascites
models. Nevertheless, the mechanistic basis for MRCK support of ovarian cancer pathogenesis remains poorly
understood. Our overall hypothesis is that MRCKs control spheroid growth and invasion of ovarian cancer cells
through the regulation of actin cytoskeleton remodeling that involves the phosphorylation and/or interaction with
proteins associated with actin and myosin signaling. To test this hypothesis, we have designed two Specific
Aims, Aim 1: Identify MRCK protein interactors/substrates that contribute to ovarian cancer using proteomics
strategies and Aim 2: Determine the effect of MRCK inhibition on spheroid viability and invasion using in vitro
and in vivo ovarian cancer models. In Aim 1, we will perform a focused analysis of our current MRCK substrate
candidates using phosphoantibodies and mass spectrometry in 2D and 3D cultures, and will decipher the
function of MRCK phosphorylation events using site-directed mutagenesis. Next, we will apply unbiased
proteomics methods to define additional interacting partners, substrates and signaling pathways controlled by
MRCK. Together, we will establish bona fide MRCK substrates and will define the mechanisms by which MRCK
promote spheroid proliferation, survival and invasion in ovarian cancer. In Aim 2, we will inhibit MRCK and
monitor viability, invasion and actin remodeling of ovarian cancer spheroids, organoids and ascites isolated from
patients with metastatic disease. Next, using a panel of orthotopic ovarian cancer patient-derived xenografts,
we will inhibit MRCK and measure in vivo tumor growth, metastasis and ascites. Together, the work proposed
here will define the mechanisms by which MRCKs promote ovarian cancer growth and metastasis and establish
MRCK as a new target in recurrent ovarian cancer.

Public health relevance
High-grade serous ovarian carcinoma (HGSOC) is the deadliest form of ovarian cancer due to frequent recurrence and metastasis with minimal treatment options. Recurrent HGSOC often spreads to the peritoneal cavity in the form of ascites, where tumor cells grow as spheroids, and metastasize to other organs causing death. The overall goal of this proposal is to uncover how protein kinases orchestrate this process, so that we can design kinase inhibitor therapies to prevent the growth and spread of recurrent HGSOC.